Targeting mitochondrial one carbon folate metabolism for novel T-cell acute lymphoblastic leukemia therapy

Project summary/Abstract
While cure rates for pediatric acute lymphoblastic leukemia (ALL) have improved dramatically over the last
several decades, ALL remains the second leading cause of cancer-related death in children. There continues
to be an unmet need for effective therapies for patients with T-cell acute lymphoblastic leukemia (T-ALL),
particularly those with relapsed or refractory disease. T-ALL is a disease generally responsive to drugs
targeting metabolism, including methotrexate and asparaginase, which form the backbone of T-ALL therapy.
Thus, I hypothesize that novel approaches to targeting metabolism may be particularly relevant in T-ALL. I
screened a panel of leukemia cell lines against small-molecule inhibitors of methylene tetrahydrofolate
dehydrogenase 2 (MTHFD2) and serine hydroxymethyltransferase 2 (SHMT2), enzymes of the mitochondrial
one carbon folate pathway, and I discovered that T-ALL cells are highly sensitive to these inhibitors, more so
than other leukemia cell lines. This proposal aims to use the small molecule inhibitors of MTHFD2 and SHMT2,
as well as genetic suppression of these enzymes, in vitro and in vivo, to study the mechanistic role of SHMT2
and MTHFD2 in T-ALL pathogenesis. The ultimate goal of the project is to develop novel therapies for patients
with T-ALL.
I am a pediatric oncologist who is seeking K08 support for mentored time in Dr. Kimberly Stegmaier's
laboratory at DFCI, with Dr. Matthew Vander Heiden at MIT as a co-mentor. My long-term career goal is to
become an independent academic physician-scientist, using genomic and chemical approaches to identify
metabolic vulnerabilities in acute leukemia with an eye toward therapeutic intervention. My prior research
experiences have established my skills in functional genomics, molecular and cellular biology and drug testing
applied to acute myeloid leukemia and T-ALL. I am now well positioned to establish the necessary expertise in
cancer metabolism, translational medicine and developmental therapeutics through the critical mentored K08
award. The Dana-Farber Cancer Institute (DFCI)/Boston Children's Hospital, Massachusetts Institute of
Technology (MIT) and the Broad Institute of MIT and Harvard are internationally recognized research programs
with a number of expert researchers in the areas of hematopoiesis, metabolism and cancer cell biology, among
others. The DFCI Division of Pediatric Oncology has a distinguished record of training young physician-
scientists for leadership roles in pediatric cancer research. I have assembled an excellent mentoring and
advisory committee, consisting of Dr. Nika Danial, Dr. Jon Aster, and Dr. Lewis Silverman, who will guide my
research and training experiences. With the structured mentoring, educational, and research plans, I will
acquire the necessary expertise to become a successful independent investigator in translational cancer
metabolism.

Public health relevance
Project Narrative While cure rates for pediatric acute lymphoblastic leukemia (ALL) have improved dramatically over the last several decades, ALL remains the second leading cause of cancer-related death in children. Enzymes of the mitochondrial one carbon folate pathway, specifically MTHFD2 and SHMT2, are highly expressed in T-ALL and are differentially expressed in cancer cells compared to normal cells. This proposal aims to understand the role of one carbon folate pathway in the T-ALL pathogenesis, and to develop a novel way to treat T-ALL by blocking the activity of MTHFD2 and SHMT2 with small molecule inhibitors.